Administrative Core

The purpose of the Administrative Core is to facilitate the research program outlined in this proposal. To this end, it will: • Provide centralized communication with all participants in the program • Organize and convene monthly meetings of the project Pis and core directors • Organize the semi-annual meetings of the Internal Advisory Committee • Organize the annual meeting of the External Advisory Committee • Coordinate annual progress reports to the NIND